Examining patterns of opioid overdose hotspots and opioid treatment deserts in California

PROJECT SUMMARY
Opioid use disorder (OUD) has proven to be a debilitating and deadly disease. Vulnerable populations
including the homeless; racial and ethnic minority groups; people in poverty; and rural residents often bear the
highest burden. Previous research suggests that localized sub-county analyses are necessary to understand
the patterns and determinants of opiate overdoses. However, most local public health departments do not have
the resources to laboriously collect, clean, and analyze the required data. We aim to provide sub-county
analyses of opioid overdose hotspots and opioid treatment deserts that will reveal actionable patterns for
California public health officials to directly address their county’s needs. Specific Aims: (1) to use
hospitalizations from 2005-2022 to detect opioid overdose hotspots using SaTScan and Bayesian spatial
modeling, (2) to use emergency medical services and treatment center location data to map opioid treatment
deserts defined by long travel times to treatment centers, and (3) to apply qualitative research methods with
county officials identifying additional local determinants of hotspots and treatment deserts not obvious from
quantitative analyses of population-level data. We will use our web platform, the Public Health Data
Ecosystem, to visualize our conclusions about the link between hotspots; treatment deserts; and the social,
economic, and environmental determinants of health. These relevant and easily comprehendible dashboards
will lend themselves directly to resource allocation, policy changes, and development of targeted interventions.
The training plan provides the skills needed for the fellowship applicant to begin a successful career as an
independent investigator in translational public health research on opioid use disorder. He will undertake
training in clinical opioid use and treatment; advanced geospatial methods and modeling; and qualitative
methods to apply and tailor research findings for public health impact. The candidate will be mentored by
faculty from across disciplines including epidemiology, psychiatry, data science, geospatial analyses, and
statistics. Dr. Nelson, the primary sponsor, leads the T32 training grant in behavioral, social, and population
health research that the candidate will continue to benefit from, and a fellow T32 director at Emory University,
Dr. Waller, will serve an important mentoring role for the application of advanced geospatial analyses. Other
mentors include leading researchers in opiate addiction from the Department of Psychiatry Drs. Humphries and
McGovern; two social epidemiology research mentors Drs. Rehkopf and Kiang; and a health psychologist
specializing in qualitative methods and citizen science Dr. King. Through this fellowship, the applicant will
advance translational methods in opioid use disorder, receive training and mentorship from world-class
sponsors and collaborators, and be prepared for independent public health research in his postdoctoral work.

Public health relevance
PROJECT NARRATIVE County public health officials have expressed the need to identify local, actionable opiate overdose trends and inform plans to reduce opiate misuse and mortality in their counties. The proposed research will examine patterns in opioid overdose hotspots; identify opioid treatment deserts; correlate outcomes with sociodemographic variables; and describe local factors contributing to opioid disparities at the sub-county level. Designing these analyses for a hyperlocal examination of opioid use disorder will inform policy, spur future innovation, and direct targeted community health interventions to address this urgent public health crisis.